Neuromodulatory regulation of cortical functional connectivity

PROJECT SUMMARY:
Neuromodulatory signaling is thought to play key roles in regulating the activity of local and long-range circuits
in the brain and in mediating behavioral state-dependent changes in circuit function and cognition. Despite
extensive anatomical evidence, there is little functional data on neuromodulatory signaling across the cortex
during behavior. Recent work has highlighted the complex, state-dependent spatiotemporal pattern of
acetylcholine (ACh) release in the neocortex. In contrast, little is known about the spatiotemporal dynamics of
norepinephrine (NE) signaling. Previous work has suggested that fluctuations in cholinergic and noradrenergic
signals may occur in tight coordination, particularly at moments of transition between behavioral states such as
quiescence and arousal. However, technical limitations have precluded simultaneous observation of multiple
neuromodulatory systems. To address these gaps, we propose to combine novel imaging approaches, including
multicolor wide-field `mesoscopic' imaging of neuronal, NE, and ACh signaling across the entire cortex in awake
behaving animals, with high-density electrophysiology and pharmacological manipulations. Using this
combination of imaging and electrophysiology, we will test the following hypotheses: (1) Noradrenergic signaling
regulates cortical activity at key transitions between behavioral states. (2) Noradrenergic and cholinergic
signaling patterns exhibit selective spatiotemporal coordination. Our results will provide an unprecedented level
of insight into the relationship between noradrenergic signaling and neocortical activity and provide novel data
on coordination between neuromodulatory systems.

Public health relevance
PROJECT NARRATIVE: Neuromodulatory systems, such as acetylcholine and norepinephrine, play a profound role in regulating the activity and function of cortical circuits. However, little is known about the spatiotemporal dynamics of neuromodulatory release during behavior and cognition. This proposal will use novel imaging techniques to determine the state-dependent pattern of noradrenergic signaling in the intact cortex, the impact of norepinephrine on cortical activity, and the coordination between different neuromodulatory systems. We expect our findings to provide important insights into neuromodulatory signaling in the healthy brain and to identify potential therapeutic targets to ameliorate pathology in disease.